Functional limitations during the transition to older age

Abstract
Overview: We propose a competitive renewal of Coronary Artery Risk Development in Young Adults Function
study (CARDIA Function; R01AG062502) at the Year 40 (Y40) in-person exam. The goals of this renewal are
to capitalize on the initial funding support provided at Y35 to obtain longitudinal assessments of function, to
validate novel measurement approaches (i.e., new composite physical performance score, remote
performance testing), to extend our innovative work on multimorbidity and function, and to identify new risk
factors for functional decline during the critical transition from midlife to early older age. Significance: Over the
next three years, >10,000 U.S. adults will turn 65 years old every day. In addition to major life changes (i.e.,
retirement, insurance) that come with the transition to older age, declines in physical function may begin to
occur in this life stage. To capture functional decline, we added the first measures of self-reported function and
physical performance (speed, balance, upper/lower body strength, endurance) to the Y35 exam in order to
identify functional decline in later exam cycles. Accomplishments of CARDIA Function include enrolling 2,030
participants (90% of Y35 in-person; mean age 60.1), establishing a Physical Function and Aging Workgroup,
publishing analyses of >30 years of data characterizing early life course development and progression of
multiple chronic conditions (i.e., multimorbidity), developing a new CARDIA Physical Performance (CAPP)
composite score, and identifying the association of multimorbidity trajectories with midlife physical function.
Continued funding will allow us to obtain repeat assessments of self-reported function and physical
performance to address 3 new scientific Aims: (1) To characterize the prevalence and incidence of functional
limitations, as well as the age of onset, progression, and severity of functional decline during the transition to
older age, (2) To determine the association between multimorbidity progression and functional decline during
the transition to older age, and (3) To identify cumulative, life-course risk factors and situational, life-stage risk
factors for both multimorbidity progression and functional decline. An overarching aim of this renewal is to
advance methods in measuring functional decline during the transition to older age including the use of
remote-administered physical performance tests. Impact: The proposed renewal at the CARDIA Y40 exam
coincides with the peak wave of the ‘baby boom’ generation who turn 65 years old through 2027. This renewal
also provides the last opportunity to measure function among participants of a decades-long prospective cohort
study during the transition from late midlife to early older age. Results will lead to new approaches to identify
functional limitations, new strategies for measuring physical performance in the age of telehealth, and new life-
stage specific targets for preventing functional decline during the transition to older age.

Public health relevance
Project Narrative The transition to older age that occurs around 65 years old can be a time of major changes such as retiring from work and taking on new family roles. For some, the transition to older age will also be associated with functional decline. The purpose of this study is to measure physical functional and identify risk factors for functional decline during the transition to older age in a group of people who have been participating in a research study since they were young adults.